Precision phenotyping of emphysema in the elderly: the MESA Lung Study

Chronic obstructive pulmonary disease (COPD) and emphysema are, jointly, the fourth leading cause of death
in the United States and third leading cause globally. COPD prevalence and mortality have doubled in the US
in the last several decades, particularly among women and minorities, despite large reductions in smoking and
in part due to population aging. The Multi-Ethnic Study of Atherosclerosis (MESA) Lung Study found that
emphysema measured quantitatively on computed tomography (CT) is common among older adults in the
general population, usually occurs in the absence of COPD on spirometry, is a strong correlate of cardiac
function, and independently predicts all-cause mortality. However, standard quantitative measures of
emphysema simplify 20-30 Mb of data per lung CT scan to one number. We therefore applied unsupervised
machine learning to emphysema-like voxels in a second study and found six highly reproducible CT
emphysema subtypes. In preliminary work we have found that genetic and environmental risk and prognosis
varies substantially by these subtypes. For this renewal of the MESA Lung Study, we therefore propose to
perform non-contrast CT, spirometry and oxygen saturation among 1,750 participants in MESA Exam 7 to
ascertain CT emphysema subtypes over 11 years and to collect nasal brushings and hair follicles for gene
expression from 500 to test if the diffuse emphysema subtype is progressive and independently predicts lung-
related hospitalizations and mortality; the obstructive CPFE subtype is progressive and independently predicts
lung-related mortality; the senile subtype is benign, and these distinct subtypes do not progress from one to
another, findings which are consistent across race/ethnic groups, among men and women, and among
smokers and nonsmokers. Second, we will examine if different environmental risk factors including ambient air
pollution and occupational exposures are associated with distinct progression of the diffuse and obstructive
CPFE subtypes. Third, we hypothesize that gene expression profiles differ between CT emphysema subtypes.
Innovative aspects of this proposal include longitudinal evaluation of CT emphysema subtypes and epithelial
cell gene expression in a large, highly genomically characterized multiethnic general-population sample.
Confirmation of the aims would help solve the conundrum of chronic lower respiratory disease, provide
precision phenotypes for ‘omic analyses, and suggest biologically based preventative and therapeutic
strategies for emphysema in the elderly.

Public health relevance
Chronic obstructive pulmonary disease (COPD) and emphysema are, jointly, the fourth leading cause of death in the United States and third leading cause globally. The Multi-Ethnic Study of Atherosclerosis (MESA) Lung Study found that emphysema measured quantitatively on computed tomography (CT) is common and morbid among older adults in the general population; however, standard measures underestimate the complexity of the disease. In this renewal, we hypothesize that machine-learned CT emphysema subtypes are distinct, have different causes and prognoses, and that distinguishing pathological emphysema from that resulting from normal aging with help the prevention and treatment of COPD and emphysema.